Structural Analyses Core

Abstract:
Core C will assist the overall goal of the Projects to test the unifying hypothesis that aging auditory neurons and
their subcellular components develop defined structural alterations, leading to profound neural circuit re-wiring
and aberrant structure/function plasticity along the auditory pathway. Core C will leverage the National Center
for Microscopy and Imaging Research (NCMIR; Dr. Perkins) resources and Dr. Fritzsch's confocal microscopy
and deep neuroanatomy expertise. Core C will use computer resources to integrate large-volume, micro- and
nano-scale structural investigations through serial block-face scanning electron microscopy (SBEM) and
confocal microscope z-series of fluorescent-tagged proteins (biomarkers), into each Project in deciphering the
structural correlates of age-related hearing loss (ARHL). Core C will provide structural support for: Project 1:
Studies of structural (anatomic) projections of spiral ganglion neurons (SGN) from inner hair cells (HCs) to the
brainstem cochlear nucleus (CN), which show age-dependent demyelination and synaptopathy using SBEM;
SGN subtype-specific projection tracing from cochlear HCs to the CN, and determination of the age-dependent
re-wiring using fluorescent-tags of SGN-subtype biomarkers. Core C will analyze axonal nodes and internodes
along the peripheral auditory neurons (AN) using Nav or Kv3.1 and CASPR immunofluorescence labeling. Other
sub-cellular changes in the aging SGN will be examined. Project 2: Studies of aging on the cochlear nucleus
(CN) using SBEM; investigation of synaptic vesicle densities and mitochondrial structure, with profound age-
dependent synaptic plasticity in ARHL models. Project 3: Connectomic analysis of nerve fibers, synapses,
dendrites, and mitochondrial networks that are altered in aging in the CN and the medial nucleus of the trapezoid
body (MNTB) using SBEM; tracking myelin thickness and the length of the internodes over relatively long tracts
of myelinated axons (central portion of the AN and axons of bushy cells to the MNTB). For all projects, the
typically large confocal and SBEM volumes will be placed in the NCMIR Cell Image Library (CIL), allowing Core
and Project researchers to annotate features in the volumes and share the annotations across sites to view in
the CIL web application interactively, and with approved researchers elsewhere. Core C will support the overall
goal in providing new insights into the current knowledge gaps in synaptic and neural overtures in aging auditory
neurons, to determine the mechanism and treatment of ARHL.

Public health relevance
Project Narrative: The purpose of Core C is to support the study of age-related hearing loss (ARHL) through a centralized resource of three-dimensional microscopy. The loss or structural remodeling of specific neurons and their components during aging will be identified in neuronal microcircuits from the inner ear to the brain's auditory centers.